Noradrenergic gating of astrocyte calcium-mediated homeostasis in vivo

PROJECT SUMMARY
Humans and mice show various brain states which are integral for survival and well-being. In awake mice, alert
brain states are distinguished by locomotion, whisking, or pupil dilation in the absence of overt behavior. These
accompany changes in neural function within the cortex such as reduced population correlation, increased
sensory response, and reduced oscillatory activity. In addition, norepinephrine (NE) levels are increased in
cortex during these activated periods. These findings are consistent with a long literature linking NE to
alertness, attention, and behavioral performance in primates and rodents. Our project is focused on
understanding changes in cortical astrocyte activity during these aroused brain states. Astrocyte calcium
activity increases during both running and pupil dilation, but the heterogeneity of this response and the relative
contribution of neuromodulators or local changes in neural activity to these astrocytic calcium events is not well
understood. Conversely, astrocyte calcium events may be important for regulating processes such as
glutamate homeostasis that directly impact neural activity on short timescales, but these effects have not been
well-characterized in vivo. Thus, the overall goal of this project is to understand the local and global factors
contributing to changes in astrocyte calcium activity and the effect of astrocyte calcium on local networks of
neurons. We hypothesize that noradrenergic neuromodulation drives calcium-mediated increases in glutamate
homeostasis that facilitate and/or support changes in local neuronal brain state. To test this hypothesis, we will
first investigate the heterogeneity of somatic and microdomain calcium waves in response to NE increases
during alert brain states. We will then test the effects of artificially reducing astrocyte calcium on state changes
in local populations of neurons, and whether reducing astrocyte calcium responses to NE locally affects
glutamate homeostasis. Our final experiment will use optogenetics to test the sufficiency of NE signaling
pathways for any observed changes and the necessity of astrocyte calcium for these induced changes. The
results of this project will more clearly define the upstream and downstream mechanisms of calcium signaling
within astrocytes across different brain states and their effect on neural populations.

Public health relevance
PROJECT NARRATIVE Mammals such as humans and mice exhibit alert and engaged brain states which are characterized by specific neural signatures. This project will determine the importance of astrocyte noradrenaline-driven responses for brain state specific neural signatures. This will provide critical information on noradrenaline response heterogeneity and possible mechanisms by which astrocytes modulate normal brain state cortical dynamics.